Cell Biology of Endosomal Escape

How do large molecules, including biological therapeutics, reach the cytosol if delivered from outside the cell?
Endocytic internalization (e.g., by clathrin-mediated endocytosis or fluid-phase uptake) is the principal route for
bringing these molecules into cells, but most internalized cargo remains entrapped until degraded in
lysosomes. Establishing potential mechanisms of endosome escape has generated long-standing
controversy, largely because of technical limitations that prevent direct detection.
Using recently developed 3D imaging modalities, especially lattice light-sheet microscopy (LLSM) and its
combination with adaptive optics (AO-LLSM), we have shown that we can observe endosomal damage and
repair and link it to events such as endosomal fission and cargo delivery. We will characterize the
mechanism(s) of the delivery events and seek ways to regulate the delivery route, with the aim of achieving a
full description of how endosomal membrane damage and repair govern endosomal escape. We will develop
novel ways to exploit the deep-learning approaches that will be essential for analyzing the huge data sets we
now generate (e.g., 3D, diffraction-limited movies of an entire cell in two or three colors at 2 sec intervals for 5
or more minutes).
Our long-term goal is to build on mechanistic understanding to work out how to enhance specific release of
desired cargo, such as antisense oligonucleotides (ASOs), microRNAs (miRNAs), and small interfering RNAs
(siRNAs), or in other circumstances, how to prevent release of deleterious cargo, such as 𝛂-synuclein and
lipopolysaccharide (LPS).

Public health relevance
We will characterize the cellular mechanism(s) of endosomal membrane damage and repair, which we can now observe directly, to relate these mechanisms to delivery of cargo into the cytosol. This understanding will facilitate development of strategies for enhancing delivery of biological therapeutics into targeted cells.